Examining Estrogenic Regulation of Orexin Neurons to Reveal Subpopulations

Title: Examining Estrogenic Regulation of Orexin Neurons to Reveal Subpopulations
Project Summary: Orexin (ORX) neurons of the hypothalamus are critical regulators of sleep and arousal, but
also important players in energy balance, stress, motivation, and reward. A persistent question has been how
can such a small (<5,000 out of 71 million neurons in a mouse) and anatomically restricted population carry out
these diverse physiological roles? Scattered reports have identified heterogeneity in ORX neurons that suggests
at least two broad groupings with the dorsomedial cells associated with arousal/activity and the lateral cells with
food and drug reward. Unfortunately, these putative subpopulations are not strictly segregated, and we lack a
reliable means of differentiating or pharmacologically targeting subgroups. This limitation has hampered the
elucidation of ORX signaling.
ORX neurons are linked to sleep disturbances, eating disorders, and anxiety, which are all disproportionately
diagnosed in females following puberty. The ORX peptide (their unique neurotransmitter) levels are higher in
both rodent and human females compared to males. Following menopause ORX levels rise and the risk of
developing many of these diseases becomes elevated. These observations indicate that transitions in estrogen
(E2) levels may contribute to disturbances in the ORX system that in turn disrupt the homeostatic function of
ORX-associated behaviors. Yet, despite these sex differences, a striking gap exists in our knowledge as to their
physiological underpinnings. However, as the hypothalamus functions as a primary link between the nervous
and endocrine systems, the majority of hypothalamic neurons are heavily regulated by E2 in females.
Typically, E2 influences hypothalamic circuits to decrease food motivation and anxiety while increasing arousal
and activity. ORX neuronal activity is associated with increased food motivation, anxiety, arousal, and activity.
Therefore, it seems unlikely that E2 can exert a uniform effect on all ORX neurons. Therefore, we propose E2
will have divergent effects on gene expression, protein translation, electrophysiological properties, and
neurotransmission in ORX subpopulations based on their roles in behavior. Specifically, we hypothesize that E2
should enhance the function of the arousal/activity subpopulation while attenuating the signaling of the food
reward subpopulation. These findings will elucidate ORX signaling while providing insight into the mechanisms
underlying sex differences in disease. A better understanding of the ORX system could help others develop
treatments to target issues with arousal and anxiety without negatively affecting food and drug reward, or vice
versa.

Public health relevance
Project Narrative: Sleep, anxiety, and eating disorders disproportionately afflict those with ovarian hormones. Hypothalamic neurons in the brain integrate metabolism and hormones to control activity and eating behavior. Through examining the regulation of these neurons by estrogen, we can better understand the factors that underlie sex differences in these disorders and how to develop new therapies to treat or prevent them.